Youth Nominated Support Team for Suicidal Adolescents at Clinical High Risk for Psychosis

PROJECT SUMMARY / ABSTRACT
Psychotic disorders are characterized by high rates of suicidal ideation and behavior, and the risk for
suicide appears to be greatest during the earliest stages of psychosis. A recent meta-analysis
showed that the majority of youth at clinical high-risk (CHR) for psychosis experience suicidal
ideation, and that approximately one in five make at least one suicide attempt. There are, however,
no suicide prevention interventions specifically tailored to the needs of transition-aged youth at CHR,
and no current best practice guidelines for how to respond to suicide risk in this population. The
Youth-Nominated Support Team (YST) intervention has recently been shown to reduce mortality
among adolescents and is potentially highly adaptable within the context of existing CHR services.
YST is intended as an adjunctive treatment and is primarily delivered towards support persons rather
than the youth themselves, and therefore would not interfere or overlap with the already extensive
direct services provided in CHR treatment settings. The proposed project intends to adapt the YST
intervention for CHR populations and to provide pilot efficacy data for a larger subsequent
randomized trial. Specifically, we aim to: (1) adapt YST for CHR based on stakeholder input (i.e.,
clients, family/friends, clinicians) and to develop a new treatment manual; (2) to implement YST in a
single CHR clinic and to revise the intervention based on input from clients, providers, and support
persons, and (3) to conduct a pilot randomized clinical trial at four SAMHSA funded CHR sites. For
the first stage of this study, we intend to conduct six focus groups (two of clients, two of family
members, and two of clinicians) to gather input on needs and preferences regarding suicide
prevention. This information will be incorporated into the YST protocol through expert consensus
meetings (i.e., study investigators, clinicians, and consultants) and used to develop a treatment
manual. During the second stage of the project, we will conduct a small feasibility study using this
intervention manual at the primary study site (N=8), and will again gather input from clients, providers,
and support persons to further revise the treatment manual. In the final stage, we will conduct a pilot
randomized clinical trial of the adapted YST intervention at four CHR clinics (N=70), comparing the
adapted YST intervention to an active control condition consisting of safety planning, crisis resources,
and means restriction. The proximal targets will be social connectedness, hope, and treatment
engagement, and the distal targets suicidal ideation and behavior (e.g., attempts, preparatory
actions). This study will provide the first clinical trial data for targeted suicide prevention among the
CHR population. Findings will inform best practices for addressing suicide risk in the CHR phase of
illness and facilitate the development of a subsequent larger randomized clinical trial incorporating
additional CHR clinics to further test the efficacy of the adapted YST intervention and to identify
underlying mechanisms of change.

Public health relevance
PROJECT NARRATIVE Suicidal ideation and behaviors are common across the psychosis continuum, particularly among youth experiencing the earliest signs and symptoms of a psychotic disorder. Despite the high risk for suicidal ideation and behavior in this group, there are currently no suicide prevention approaches specifically designed for youth at clinical high-risk for psychosis. This project will adapt the evidence-based “Youth-Nominated Support Teams” intervention, tailoring it for transition-aged youth and young adults receiving clinical high-risk for psychosis mental health services. Using client, family, and stakeholder input, we will develop, implement, and revise the intervention, and then test its impact in a preliminary randomized trial at four psychosis-risk clinics.